Pharmacokinetics-Based DNA-Encoded Library Screening

PROJECT ABSTRACT
This K99/R00 proposal seeks to expand the space of druggable protein targets through the
development of novel analytical technology that will guide the design of next-generation, non-
Lipinski molecular therapeutics and diagnostics. Cyclic peptides, which are not drug-like (i.e., Lipinski-
like), hold great promise for addressing undruggable targets, especially protein-protein interactions (PPIs).
However, the larger molecular mass and more complex secondary structures result in unpredictable and almost
always low cell permeation, significantly blunting their utility as drug candidates and even as preclinical tool
compounds in cells. Rarely, a cyclic peptide will exhibit anomalously high permeation. However, insufficient data
exist to uncover the rules dictating permeation because high-throughput measurements of cell permeation
simply do not exist. In this proposal, a high-throughput in vitro permeation assay compatible with DNA-encoded
combinatorial library (DEL) screening will be developed and miniaturized to the microfluidic droplet scale. The
permeation assay will be applied to screen DELs to identify the species that efficiently permeate membrane
bilayers. The permeable macrocycle hits will be further validated in a cell-based permeation assay that will also
be developed in the project. The large screening data sets will reveal relationships between permeability and
structure, especially for molecules of beyond the Rule of 5 (bRo5), which will be further analyzed using machine
learning. With these and other empirically derived models of macrocyclic peptide pharmacokinetic properties in
hand, we may finally be able to move such non-Lipinski molecules from the lab to the clinic at scale. This proposal
will significantly enhance the PI’s career development and advance her toward her career goal of becoming an
independent investigator at a research-focused institution. The proposed project provides training in cutting-
edge research skills, including cell-based assay development and high-content imaging, DEL design, synthesis
and screening technology development, and machine learning techniques. UC Irvine provides an ideal
environment for academic training, with world-renowned experts in medicinal and computational chemistry,
chemical biology and microfluidics engineering. In addition, UCI provides an intellectual environment that
encourages collaboration and cooperation, enabling the candidate’s growth as a member of the scientific
community. Indeed, the PI will engage in activities designed to achieve independence, including training in lab
management and grantsmanship, networking, and preparation for the academic job market. In summary, the
proposed plan will enable the PI’s scientific and career-wise growth and independence, further positioning her
to attain future R01 funding.

Public health relevance
PROJECT NARRATIVE Only 4% of the human proteome (20,171 human proteins) has been liganded by chemical probes. The majority of the proteome is undruggable by small molecules. Cyclic peptides are considered as promising molecules to address the undruggable targets, but its larger molecular mass and more complex secondary structures result in unpredictable and almost always low cell permeation, significantly limiting their utility as drug candidates. This proposal will develop analytical assays and tools for the detection and screening of cell-penetrating cyclic peptides as tool compounds for platform development. Screening results will be used to build machine learning models of permeation and inform its applications in next-generation diagnostics and therapeutics.